Einstein-Mount Sinai Diabetes Research Center

SUMMARY/ABSTRACT:
Due to the high mortality (>2% of infected individuals world-wide) with ~25% of infected
individuals developing post-acute COVID-19 syndromes, the National Institute of Diabetes,
Digestive and Kidney Diseases (NIDDK) organized a taskforce composed of Diabetes Research
Centers (DRCs) and Centers for Diabetes Translational Research (CDTRs) to explore research
directions that should be harnessed to address the issues associated with COVID-19 and
metabolism. Two related efforts were broadly agreed upon to be of important current and future
value and were endorsed at the Spring NIDDK Council meeting. This application for a
Supplement represents our formal request for NIDDK funds to support the second year of a
novel research program that will take advantage of the established of the NIDDK funded DRC
and CDTR infrastructures.
Within this framework, there are two overarching goals. The immediate goal is to foster
COVID-19 metabolism research which leverages the existing technologies and strengths that
exist with the national DRC and CDTR programs. The long-term goal is to develop a work flow
for expanding national research collaborations across the diabetes/obesity and metabolic
disease research communities at the basic, clinical, translational, community and health
disparity levels. To accomplish these objectives, we propose to continue the second year of
funding for the three active awards that we have support in year 01.

Public health relevance
NARRATIVE: This is a supplement application for our funded Einstein-Mount Sinai regional Diabetes Research Center award (P30 DK020541) to continue the national funding for participating Diabetes Research Centers (DRC) and Center for Diabetes Translational Research Centers (CDTR). These funds will be used to provide second year support for the three national Pilot & feasibility awards that were funded in year 01.